Molecular mechanisms of sex-specific deficits in neurodevelopmental disease

ABSTRACT
Autism Spectrum Disorder (ASD) and other neurodevelopmental disorders (NDDs) are more prevalent in males,
but the molecular mechanisms behind this sex bias are unclear. This proposal investigates how hormones and
sex-specific signaling interact in developing behavioral deficits, using mouse models of Coiled-coil and C2
domain containing 1a (Cc2d1a) loss-of-function. Human biallelic null mutations in CC2D1A cause intellectual
disability (ID), ASD, and seizures. Male Cc2d1a-deficient mice display behavioral deficits that recapitulate
features of ASD (reduced cognition and sociability), which are absent in females. CC2D1A is a signaling scaffold
that modulates cyclic AMP (cAMP) signaling, crucial for synaptic plasticity and learning and memory. Our
previous research showed sex-specific disruptions in cAMP signaling in the hippocampus of Cc2d1a-deficient
males, that could be rescued only in males by modulating cAMP levels. This indicates that CC2D1A loss leads
to sex-specific brain signaling deficits affecting cognition and sociability in males only.
We hypothesize that gonadal hormones establish these sex-specific signaling deficits upstream of CC2D1A
function leading to distinct male and female behavioral outcomes. However, gonadal hormones can act at
different developmental stages to establish sex-specific mechanisms with organizational role early after birth and
activational (acute) roles after puberty. Early postnatal lethality in global Cc2d1a knockout (KO) mice previously
hindered these studies as the two timepoints could not be studied in the same animal. We recently generated a
new hypomorphic mouse strain with a 90% reduction in CC2D1A levels that allows hormone modulation at
various times during development.
Our expertise in CC2D1A function complemental with advice from an expert neuroendocrinologist perfectly
position us to conduct the proposed research. In Specific Aim 1, we will determine whether gonadal hormones
cause male-specific behavioral deficits in Cc2d1a-deficient mice through organizational or activational action.
We will treat female pups with estrogen postnatally to mimic the male testosterone surge and reduce
estrogen/testosterone levels in adults via ovariectomy or orchidectomy. In Specific Aim 2, we will probe the
molecular mechanism underlying how sex hormones establish sex-specific intracellular signaling in neuronal
cultures from Cc2d1a KO and hypomorph mice. This combined approach will
These studies will explore a new molecular mechanism for sex-specific cognitive deficits, also informing whether
therapeutic approaches should be sex-specific.

Public health relevance
NARRATIVE This study explores why Autism Spectrum Disorder (ASD) and other neurodevelopmental disorders are more common in males by investigating how sex hormones can establish sex-specific molecular changes in the brain and leading to sex-specific behavioral deficits. By understanding these sex-specific differences, our research aims to understand the cellular mechanisms of male bias in ASD diagnosis to better target treatments in males and females.